EFFECT OF ANGIOTENSIN II ON HUMAN ENDOTHELIAL FUNCTION

The purpose of this study is to learn how angiotensin II, a substance normally circulating in your blood at low levels, affects blood vessel function.